Transdisciplinary Research in Energetics and Cancer (TREC) Training Grant

Abstract
Given the rising prevalence of obesity, poor diet and physical inactivity, known in combination as “energy
balance” or “energetics”, as well as their associations with cancer incidence and mortality, innovative research,
clinical care and training of scientists are needed to lower the prevalence of these risk factors and in turn, lower
cancer incidence and mortality rates. In September 2020, the NCI released its Fiscal Year 2022 Budget
proposal, which includes obesity and cancer as a featured scientific topic and training the next generation of
cancer researchers as a key investment. With NCI R25 support from 2016-2021, we developed and offered an
annual one-week, in-residence Transdisciplinary Research in Energetics and Cancer (TREC) Training Course,
followed by a yearlong mentoring program, that focused on energy balance and cancer research across the
cancer control continuum. The overall goals of this Program were to educate, train and mentor 100 early
career investigators, called TREC Fellows, from diverse academic backgrounds (i.e., basic, clinical and
population sciences) in transdisciplinary research in energetics and cancer. For the first four years of TREC,
we admitted and trained 97 Fellows from 57 different institutions. We are in our 5th year of our TREC Program
and expect to recruit 20 more Fellows, for a total of 117 Fellows completing the TREC Training Program.
TREC Fellows have published 270 manuscripts in peer-reviewed journals, with 62 published manuscripts
including the TREC Fellow as first or senior author and including a TREC Faculty and/or Fellow as co-author.
Since completing the Program, TREC Fellows have received 31 extramural grants, as principal investigator.
Building upon the strengths of the previous five years but responsive to additional opportunities for training and
further dissemination of the course, the goals of our competitive renewal are: 1) to offer a hybrid TREC
Training Program with virtual TREC Faculty-led programs before the in-person workshop focused on
increasing content knowledge; 2) followed by a 5-day in-person workshop focused on the Fellows’ research,
networking and professional development; and 3) year-long mentorship between the Fellow and Faculty
Mentor and Peer Mentor. Led by Dr. Melinda Irwin and drawing from the resources of the Yale School of Public
Health, Yale Cancer Center, and ~20 expert TREC Faculty from across the country and 100+ TREC Fellow
alumni from around the world, our TREC Program is innovative in that currently no training opportunity exists
that focuses on energetics and cancer research. Our goal is to continue the TREC mission of training scientists
to develop a cadre of well-trained, diverse researchers. The overall impact of this program will be defined by
the degree to which TREC Fellows produce innovative research approaches and discoveries, thereby
accelerating the dissemination and implementation of evidence-based approaches into everyday practice and
patient care, in turn improving the health of the population at risk for cancer as well as cancer survivors.

Public health relevance
Narrative The overall goal of this NCI R25 competitive renewal research education program is to offer, evaluate and disseminate a transdisciplinary research in energetics and cancer (TREC) Training Program with virtual educational programs, a 5-day in-person workshop and a year-long mentorship program for early career investigators, with the goal of enhancing the ability of participants to conduct innovative, transdisciplinary research in energetics and cancer research and clinical care. Our TREC Training Program is highly innovative in that currently no training opportunity, course or workshop exists that focuses on energetics and cancer research. The overall impact of this transdisciplinary training program will be defined by the degree to which program participants produce novel and innovative research approaches and discoveries (through funding, presentations and publications), which in turn, may improve the health of the population at risk for cancer as well as cancer survivors.